Investigating novel mitochondrial mechanisms of obesity pathogenesis

Obesity causes mitochondrial dysfunction, disrupting lipid homeostasis, adipogenesis, and energy expenditure.
The mechanisms underlying mitochondrial dysfunction in obesity are not fully understood. The proposed
research will test a novel mechanism to restore mitochondrial function and mitigate metabolic disease caused
by obesity. This plan centers on rhodoquinone (RQ), a previously unknown mammalian metabolite that my lab
discovered in preliminary work to be enriched in mouse and human adipose tissues. RQ carries electrons in the
mitochondrial electron transport chain (ETC) on a noncanonical path whereby fumarate, instead of O2, is the
electron acceptor (Valeros et al., In revision). The fundamental role of the RQ/fumarate pathway in adipogenesis,
and its therapeutic potential in obesity have never been studied. Preliminary data reveal that RQ levels rise
specifically in the adipose depots of obese mice, and that providing RQ to differentiating adipocytes
drives lipid accumulation. Moreover, treating mice with RQ during diet-induced obesity profoundly reduces
fatty liver, suggesting that reprograming the ETC to the RQ/fumarate pathway improves systemic lipid
handling. These preliminary data inspired the overarching hypothesis that adipocytes engage the RQ/fumarate
ETC as a defense mechanism during obesity, rewiring mitochondrial metabolism to enable storage of excess
lipids. Moreover, we anticipate that further elevating RQ during obesity onset will improve lipid storage in adipose
tissue, reduce ectopic lipid deposition, and consequently mitigate metabolic disease. To address these
hypotheses, the first aim will elucidate the mechanism by which the RQ/fumarate ETC circuit drives lipid
accumulation during adipogenesis. Specifically, this aim will establish the point of differentiation that adipocytes
reprogram their ETC to the RQ/fumarate pathway and measure its impact on mitochondrial functions.
Additionally, this aim will test how RQ drives lipid buildup by monitoring lipolysis, lipogenesis, and fatty acid
oxidation on in-house high resolution mass spectrometers. The second aim will test the therapeutic potential of
reprogramming the ETC to the RQ/fumarate pathway in obesity. This aim leverages first-in-class genetic and
pharmacologic tools developed by my lab that reprogram the ETC to the RQ/fumarate pathway in vivo.
Specifically, we will analyze the impact of RQ on insulin sensitivity, glucose tolerance, and circulating triglyceride
levels in lean and obese models. Also, whole-body lipid deposition, weight gain, activity, and respiratory rate will
be measured in collaboration with experts at the UMass Chan Medical School Metabolic Disease Research
Center. Our toolkit uniquely positions us to address the fundamental role of RQ, a previously unstudied
metabolite, in lipid homeostasis throughout adipogenesis. Moreover, this study will use these tools to test, for
the first time, the therapeutic potential of reprogramming the ETC as a strategy to treat diseases such as obesity.
Regardless of the outcomes, the proposed research will lay the foundation for a new field of adipose biology on
flexibility in the mitochondrial ETC that will ignite the field for decades to come.

Public health relevance
Obesity leads to mitochondrial dysfunction, impairing lipid homeostasis and energy expenditure, however, the mechanisms underlying mitochondrial dysfunction in obesity are not fully understood. This research will build upon exciting preliminary data to explore the role of a novel mitochondrial metabolite in healthy and obese adipogenesis. Leveraging a unique toolkit to reprogram mitochondrial metabolism, this work will identify the mechanism through which this metabolite impacts lipid storage in human adipocytes and obese mice, and test a novel therapeutic strategy that targets this pathway to combat obesity-related metabolic disease.